Hormone Regulation and Pathogenesis of Pituitary Tumors

To characterize and define the role of MEG3, a pituitary derived gene, to increase the understating of its role in human pituitary tumors which represent up to 40% of all diagnosed pituitary neoplasms. These tumors commonly lead to visual loss and many other severe neurologic and endocrine deficits.

Public health relevance
Project Narrative Human pituitary tumors of a gonadotroph cell origin represent up to 40% of all diagnosed pituitary neoplasms, can cause visual loss and other neurologic deficits, and have no established medical treatment. We have found a pituitary-derived gene, MEG3, which may function as a tumor suppressor. Investigation of the function of this gene will provide important information regarding the pathogenesis of human pituitary adenomas, and, potentially, other human tumors.